Core E Informatics

INFORMATICS CORE – CORE E: PROJECT SUMMARY/ABSTRACT
The BIOCARD study is a longitudinal, observational study of 349 individuals who were cognitively normal and
primarily middle aged (mean age=57.1) at enrollment. The subjects have now been followed for up to 27 years.
The overall objectives of the project are to further advance the study of preclinical Alzheimer’s disease
by: (1) clarifying the pattern and rate of change in AD biomarkers (including those based on CSF, blood, MRI,
and PET imaging) and cognition; the biomarkers to be studied include several promising novel biomarkers
derived from blood, CSF and brain imaging. (2) maximizing our data by working collaboratively with several
research groups who have comparable data, and (3) providing a publicly accessible data, brain scans, and
biological specimens, for researchers in the field. To accomplish these goals we established 7 Cores and, with
this application, are also including 2 projects. The Informatics Core (Core E) is responsible for the
management and dissemination of the data from the BIOCARD study. The specific aims include: (1) to
oversee all data management aspects of the study, (2) to prepare data files for analyses by the Biostatistics
Core as well as other investigators associated with the study, (3) to maintain the web-based BIOCARD data
system, including the design of data collection forms, data capture, data editing and data management, (4) to
update and maintain the BIOCARD website, (5) to coordinate data sharing with external investigators, and (6)
to prepare datasets for external investigators.